Core 1 Biostatistics/Bioinformatics Core

The goal of the Biostatistics/Bioinformatics Core is to collaborate with SPORE Investigators and other Core
resource scientists to enhance the quality of the research undertaken in the Michigan Prostate SPORE. The
Core personnel have been chosen because of their expertise in relevant areas of Biostatistics and
Bioinformatics that is specifically required for the SPORE projects to succeed. Support will be provided in all
stages of the research, beginning with the formulation of the research question, through the experimental
design stage and data collection stage, including genomic sequencing, data analysis, and interpretation, to the
writing of reports and dissemination of results. It will be apparent from this proposal that Core personnel have
played a significant role in designing the proposed experiments and planning the data analyses. The exact
nature of the collaboration will depend on the specifics of the science and the needs of the project. In addition
to direct support of the projects and other Cores, senior statisticians will also focus on statistical methodology
development and the advancement of genomic/bioinformatic capabilities related to the needs of prostate cancer
research in this SPORE. Thus, the Specific Aims of the Core are:
1) Assist Investigators in the design of clinical, laboratory, and high-throughput genomic sequencing
experiments;
2) Assist Investigators in the analysis and interpretation of data from clinical and laboratory experiments,
the processing and examination of high-throughput genomic datasets, and in writing of manuscripts
relaying Michigan Prostate SPORE results to the scientific community;
3) Undertake translational biostatistics/bioinformatics research to develop methodology and software
implementation relevant to prostate cancer including the development of algorithmic toolkits for
emerging types of genomic assays and the adaptation/refinement of existing computational
approaches to the needs of the Michigan Prostate SPORE;
4) To establish a center of excellence for immunogenomics in prostate cancer. The center will provide
state-of-art support for interdisciplinary research at the interface of cancer immunology and
genomics and facilitate the rapid clinical translation of immunogenomic findings.
The Biostatistics/Bioinformatics Core will be led by Dr. Alexander Tsodikov, Ph.D., a Professor of Biostatistics at
U-M. He has served as the Director of the Prostate SPORE Biostatistics Core since 2009 and has substantial
experience in the development of mechanistic statistical models of prostate cancer and biostatistical
methodology and software, and statistical models in cancer. Drs. Jeremy Taylor, Ph.D. (U-M), Hui Jiang, Ph.D.
(U-M), Lance Heilbrun, Ph.D. (KCI), and Marcin Cieslik, Ph.D. (U-M), will serve as Co-Investigators.

Public health relevance
The Biostatistics/Bioinformatics Core is critical to the ongoing success of the Michigan Prostate SPORE. It has contributed to the success of the current projects and has participated in a meaningful way in the planning and design of the proposed projects. Our ultimate goal is to decrease the morbidity and mortality of prostate cancer through innovative research that is supported by rigorous biostatistical and bioinformatics support.